TESTING INSULT ACCUMULATION WITH COMPETING MODELS

THIS IS A SHANNON AWARD PROVIDING PARTIAL SUPPORT FOR THE RESEARCH PROJECTS THAT FALL SHORT OF THE ASSIGNED INSTITUTE'S FUNDING RANGE BUT ARE IN THE MARGIN OF EXCELLENCE. THE SHANNON AWARD IS INTENDED TO PROVIDE SUPPORT TO TEST THE FEASIBILITY OF THE APPROACH; DEVELOP FURTHER TESTS AND REFINE RESEARCH TECHNIQUES; PERFORM SECONDARY ANALYSIS OR AVAILABLE DATA SETS; OR CONDUCT DISCRETE PROJECTS THAT CAN DEMONSTRATE THE PI'S RESEARCH CAPABILITIES OR LEND ADDITIONAL WEIGHT TO AN ALREADY MERITORIOUS APPLICATION. THE ABSTRACT BELOW IS TAKEN FROM THE ORIGINAL DOCUMENT SUBMITTED BY THE PRINCIPAL INVESTIGATOR. DESCRIPTION: The proposed research will compare the effects of two models by which health experience in early adulthood is believed to influence later health and the timing of death. In the natural history of disease model, the expectation is that specific diseases predict subsequent health problems. In the generalized insult accumulation model, the expectation is that diseases and injuries in general qualify as insults that influence later health problems. These models will be compared using data on 1451 men and women who belonged to friendly societies in Australia in the period 1893-1974.